Molecular Mechanisms of GABAergic Synapse Modulation by TAFA

Project Summary
Experience- or use-dependent synapse formation and elimination in neurons are critical for the development
and maintenance of neural circuits and information storage. Aberrant control of these processes is thought
responsible for numerous neurological and psychiatric diseases. The long-term goal is to better understand the
molecular mechanisms by which activity regulates synapse formation and elimination to adjust neural circuit
function and behavior. Inhibitory synaptic transmission via GABAergic synapses is critical for shaping network
activity and maintaining neural circuit functionality. Defective and aberrant GABAergic synapses are associated
with multiple neuropsychological conditions including chronic pain, mood disorders, schizophrenia, and
Alzheimer's disease. Like excitatory synapses, inhibitory synapses are highly dynamic and undergo activity-
dependent turnover processes not only during early development but also in adult brain. However, molecular
mechanisms involved in the regulated elimination of inhibitory synapses are poorly understood.
Neuromodulators play important roles in providing flexibility for neural circuit operation and behavior. Although
there is a growing body of evidence indicating the important role of neuromodulators in the control of GABA
synapses, specific neuromodulator(s) involved in the weakening and elimination of GABAergic synapses
remains to be identified. TAFA2 is a brain-specific, novel chemokine-like protein expressed by neurons. Recent
studies using TAFA2 gene knockout animals indicate that TAFA2 is involved in anxiety and fear responses.
However, molecular mechanisms by which TAFA2 performs its functions in the brain remain unknown. The
central hypothesis of this project is that TAFA2 is a novel neuromodulator involved in the activity-dependent
elimination of inhibitory synapses. This hypothesis has been formulated based on the preliminary data showing
that overexpression and knockdown of TAFA2 had strong effects on the strength and numbers of GABAergic
synapses in cultured hippocampal neurons. The objective of the project is thus to characterize and study the
function of TAFA2 in the control of GABAergic synaptic transmission and synapse numbers. By using
multidisciplinary approaches including biochemistry, advanced imaging techniques, electrophysiology, and
CRISPR-Cas9 genome editing, the following three specific aims will be pursued to test the central hypothesis:
1) Examine the rapid modulatory effect of TAFA2 on GABAergic synaptic transmission. 2) Establish TAFA2
function in the elimination of GABAergic synapses in vivo utilizing TAFA2 knockout mice. 3) Investigate
mechanisms of TAFA2 action by delineating downstream signal transduction pathway and identifying its
receptor candidates. The proposed research is significant, because it is expected to advance and expand the
current understanding of the molecular mechanisms involved in the dynamic control of synapse strength and
numbers. Moreover, such knowledge ultimately may help to identify new therapeutic targets for
neuropsychological disorders.

Public health relevance
Project Narrative The proposed research is highly relevant to public health because the characterization of new neuromodulatory mechanisms of inhibitory synapses is important for better understanding of human cognitive function. Moreover, the knowledge obtained from this project might provide new therapeutic targets for the treatment of numerous diseases including chronic pain, mood disorders, anxiety disorders, schizophrenia, and Alzheimer's disease. Therefore, the proposed research is also relevant to the part of NIH's mission that is related to developing fundamental knowledge about diseases for reducing burdens of human disability.